Targeting Troponin T Regulation to Sustain Cardiac Function in Heart Failure

Project Title: Targeting Troponin T Regulation to Sustain Cardiac Function in Heart Failure
Project Summary
Sufficient blood pumping of the heart depends on ventricular filling and the contractility of cardiac muscle
against arterial resistance. Cardiac insufficiency and failure remains a major challenge in the management of
cardiovascular diseases. Cardiac muscle contraction and relaxation is regulated by the troponin complex in the
sarcomeric thin filament. Troponin consists of three protein subunits: troponin C (TnC), troponin I (TnI), and
troponin T (TnT). A restrictive proteolytic cleavage to selectively remove the N-terminal hypervariable region of
cardiac TnT (cTnT) occurs as a physiological adaptation to ventricular inotropy-afterload mismatch such as
that in acute myocardial ischemia or pressure overload. The N-terminal truncated cTnT (cTnT-ND) remains in
the cardiac myofilaments with modified functionality to moderately tune down ventricular peak-systolic velocity,
which elongates the time of rapid ejection to sustain stroke volume. Without increasing the peak systolic
pressure, this myocardial kinetics-based mechanism also improves the efficiency of cardiac pumping.
Based on strong scientific premise, substantial progresses made in the previous funding period of this
research project and promising preliminary studies, the proposed new studies focus on investigating the
molecular mechanism by which cTnT-ND modulates the kinetics of cardiac myofilament activation and
deactivation via the newly identified C-terminal tropomyosin-binding site 3 of TnT for translational applications
in treating inotropy-afterload mismatch and diastolic dysfunction of failing hearts. Three new Specific Aims will
be pursued:
Aim 1 is to characterize how the newly identified tropomyosin-binding site 3 in the C-terminal end segment
of TnT functions in tuning the kinetics of cardiac myofilament activation and deactivation.
Aim 2 is to assess the effects of cTnT-ND on ventricular systolic and diastolic kinetics in improving cardiac
function in heart failures with reduced ejection fraction (HFrEF) and with preserved ejection fraction (HFpEF).
Aim 3 is to develop applications of TnT C-terminal peptides in correcting the function of failing hearts.
Significance: b-adrenergic blockade has a proven clinical benefit in treating chronic congestive heart
failure and prolonging patient life. Without the side effects from systemic decrease in b-adrenergic tone, the
cTnT-ND adaptation via the C-terminal tropomyosin-binding site 3 selectively tunes down myocardial peak-
systolic velocity to elongate ventricular rapid ejection time and sustain stroke volume against afterload. This
myofilament mechanism simulates a therapeutic effect of b-adrenergic blockade and targets a specific kinetic
step of the cardiac cycle to improve pumping efficiency in failing hearts. This mechanism can also facilitate
relaxation to alleviate myocardial hypertrophy- and over activation-caused diastolic dysfunction in diastolic
heart failure. Our studies using integrative multi-level approaches and experimental systems will lay
groundwork for ultimately translating this novel molecular mechanism into a new treatment for heart failure.

Public health relevance
Project Title: Targeting Troponin T Regulation to Sustain Cardiac Function in Heart Failure Project Narrative Cardiac troponin T is a subunit of the troponin complex that regulates cardiac muscle contraction. A restrictive proteolytic truncation selectively removing the N-terminal variable region of cardiac troponin T occurs in physiological adaptation to sustain ventricular stroke volume in failing hearts. This myofilament kinetic mechanism will be studied using integrative research approaches aiming at applications in improving cardiac function and pumping efficiency as a new treatment for heart failure.